Multiplexed proteomics-based kinase assay development

R01GM146386 – Supplement for Summer Undergraduate Researcher – Project Summary
This supplement project is to support the research training and professional development for an undergraduate
researcher. The student (from University of Minnesota) will work across the parent grant principal investigator's
laboratory and the collaborator's laboratory, to embed their training in both environments. This should enhance
both the candidate's training experience and the project's progress by explicitly and directly linking the
experimental planning and execution between the two labs, one basic science and one more translationally
connected. In this supplement project, the student will prepare samples under varying conditions in the L. Parker
lab, testing different peptide concentrations and incubation times in two cell lines. These samples and additional
peptides (both unlabeled peptides and stable isotope labeled standards) will be brought to the S. Parker lab at
Cedars Sinai. The candidate will learn the sample processing and preparation for proteomics, targeted parallel
reaction monitoring (PRM) analysis both from the instrumentation side and the data analysis side, and also have
opportunities to enhance professional development through presenting their project to the lab groups, and
interact with scientists and physicians in the highly dynamic, cutting-edge translational setting at Cedars Sinai
Medical Center.

Public health relevance
R01GM146386 – Supplement for Summer Undergraduate Researcher – Project Narrative This supplement project is to support the research training and professional development for an undergraduate researcher. The student (from University of Minnesota) will work across the parent grant principal investigator's laboratory and the collaborator's laboratory, to embed their training in both environments. This should enhance both the candidate's training experience and the project's progress by explicitly and directly linking the experimental planning and execution between the two labs, one basic science and one more translationally connected.